Molecular Genetic Mechanisms of Infantile Epilepsies and the Impact of Genetic Diagnosis

PROJECT SUMMARY/ABSTRACT
Epilepsies with onset in the first year of life are common, affecting 1 in 1000 infants, and are associated
with significant morbidity, notably drug-resistant seizures and impaired developmental outcomes, and
increased mortality. Although most infantile epilepsies have presumed molecular genetic etiologies, most
cases remain genetically “unsolved” and the full molecular genetic landscape is unknown, which limits our
ability to develop effective precision therapies. Further, the impact of genetic diagnosis in infantile epilepsies is
largely unknown, which limits our ability to broadly implement genetic testing for this population.
This proposal will address these knowledge gaps by identifying novel molecular genetic etiologies
(genetic diagnoses) and evaluating their impact in a prospectively enrolled, longitudinally followed cohort of
infants with unexplained epilepsy. Aim 1 will apply cutting-edge, comprehensive genomic analyses to identify
novel genetic etiologies of infantile epilepsies, using short-read and long-read genome sequencing to identify
pathogenic germline variants (Aim 1a) and deep sequencing to identify pathogenic mosaic variants (Aim 1b).
Aim 2 will evaluate the multidimensional impact of genetic diagnosis (or lack thereof), using a validated
measure of clinical utility and follow up of developmental progress and seizure frequency to assess impact on
infants (Aim 2a) and a validated measure of parent-perceived utility and interviews with parents to assess
impact on families (Aim 2b). The insights from this proposal will advance scientific knowledge and clinical care,
with immediate diagnostic and therapeutic implications for infants with epilepsy, with the ultimate goal of
advancing precision medicine and improving outcomes for this vulnerable population.
Dr. D’Gama is a neonatologist with prior experience in basic neurogenetics research whose career goal
is to become an independent physician-scientist at an academic medical center with a translational research
program focused on precision medicine for infantile epilepsies and related neurogenetic disorders. Through the
proposed K23 training program, Dr. D’Gama will gain new knowledge and skills in patient-oriented clinical and
translational research, including advanced genomic sequencing and analyses, neonatal and infantile epilepsy
phenotyping, epidemiology and biostatistics, qualitative analyses, and human subjects and clinical trials
research, which will position her to successfully transition to independence. Dr. D’Gama’s mentor, Dr.
Annapurna Poduri, is a leader in pediatric epilepsy and epilepsy genetics research, and her co-mentor, Dr.
Margaret Parker, is a leader in neonatology and health services research. Both Drs. Poduri and Parker have
extensive mentorship track records and Dr. D’Gama has also assembled a Scientific Advisory Committee and
collaborators with complementary expertise. The institutional resources and intellectual community available
through Boston Children’s Hospital and Harvard Medical School are world-class and will provide an ideal
environment for Dr. D’Gama’s career development as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Infantile epilepsies are common, affecting 1 in 1000 infants, and are associated with significant morbidity, mortality, healthcare costs, and caregiver burden. Although most infantile epilepsies are believed to have genetic causes, most infants with epilepsy remain genetically “unsolved” and the full genetic landscape of infantile epilepsies is unknown, which limits our ability to develop precision therapies and ultimately improve outcomes for this vulnerable population. This proposal aims to discover new genetic causes of infantile epilepsies and evaluate the impact of these discoveries on infants with epilepsy and their families, contributing to knowledge that will inform our scientific understanding of normal and abnormal brain development and guide clinical care and implementation of precision medicine for infants with epilepsy.